NEUROPATHOLOGIC STUDIES OF POST MORTEM BRAIN OF SCHIZOPHRENIC PATIENTS

The objective of this study is to search for evidence of anomalous innervation or regeneration in specific nuclei of schizophrenic brains. Formalin-fixed, paraffin-embedded, 50 mum matched sections of nucleus accumbens from eight age-and sex-matched control brains were used for studies of morphology and possible axonal sprouting. Using a monoclonal antibody against nonphosphorylated neurofilaments, we compared innervation patterns in limbic forebrain of schizophrenic and control brains at matched levels. A slight decrease in axons and a change in axon pattern was seen in the grouped schizophrenic specimens.